Career Development Program

PROJECT SUMMARY ABSTRACT The Career Development Program is designed to increase the translational investigator base in the Mayo Myeloma SPORE by identifying and fostering the early careers of young investigators who have an interest in multiple myeloma translational research. In particular, this program provides much-needed support for promising young laboratory or clinical investigators early in their careers so that they can focus their energies on research projects related to multiple myeloma research. We have requested $50,000 in this application to support this program. Mayo, as part of its commitment through the Mayo Comprehensive Cancer Center, has agreed to match these funds. Thus, we would plan to commit a total of $100,000 to the career development program. The Career Development Program makes maximal use of the scientific expertise within the Mayo community. The Career Development Program Committee is responsible for organizing the program and reviewing research proposals as submitted.

Public health relevance
PROJECT NARRATIVE The purpose of this program is to support and mentor young investigators at the junior faculty level so that they can become outstanding translational investigators with a primary focus on multiple myeloma. Each individual selected for the project is provided 2 years of salary support ($50,000 per year). Each awardee is expected to spend the 2 years engaged in multiple myeloma translational research under the aegis of a suitable mentor. Again, support for only one of these individuals is being requested by the grant. Developmental funds from the Mayo Comprehensive Cancer Center will.